CT DoAg/CAES Conformance with the Animal Feed Regulatory Program Standards (AFRPS) (U18)

PROJECT ABSTRACT: CT DOAG/CAES CONFORMANCE WITH THE ANIMAL FEED REGULATORY PROGRAM STANDARDS (AFRPS) (U18) The specific goal of this project is to establish a cooperative agreement with FDA to advance efforts at achieving a nationally integrated feed safety system. In CT, this will occur by using this funding in two key ways. First, the funding will enable the state feed regulatory program at the CT Department of Agriculture (CT DoAg) to fully implement and maintain the Animal Feed Regulatory Program Standards (AFRPS), which will be in conjunction with a new feed safety inspection contract. Second, funding will enable the Connecticut Agricultural Experiment Station Department of Analytical Chemistry (CAES), the laboratory that provides chemical analysis for the CT DoAg, to bring animal feed analysis under ISO/IEC 17025:2005 accreditation. CAES is currently funded under the FDA MFRPS ISO CAP and the AFRPS cooperative agreement will allow an expansion of our accredited programs to include animal feeds. Specifically, analysis will involve select mycotoxins and antibiotics in a range of animal feeds. Collectively, funding under AFRPS will enable both the regulatory and laboratory components of animal feed work to significantly expand our respective programs and for CT to meaningfully participate in the process of promoting a nationally integrated feed safety system.

Public health relevance
The Connecticut Agricultural Experiment Station 123 HUNTINGTON STREET, P.O. BOX 1106, NEW HAVEN, CONNECTICUT 06504 Putting Science to Work for Society Protecting Agriculture, Public Health, and the Environment Founded 1875 RFA-FD-15-021 Implementation of the Animal Feed Regulatory Program Standards (AFRPS) (U18) Please see the included PHS 398 Research Plan, 3. Research Strategy for the full project narrative for the proposal entitled “CT DoAg/CAES Conformance with the Animal Feed Regulatory Program Standards (AFRPS) (U18).” This is a joint application under Competition C between the state animal feed regulatory program (CT Department of Agriculture) and the CT Agricultural Experiment Station that provides chemical analysis. Included in that document is the RFA specific required information for both groups. Wayne Kasacek, BS, RS Assistant Director CT Dept. of Agriculture Bureau of Regulation and Inspection 860.713.2508 [email] Jason C. White, Ph.D. Vice Director and Chief Analytical Chemist Connecticut Agricultural Experiment Station 123 Huntington Street New Haven, CT 06504 203-974-8523 [email] Phone: (203) 974-8500 Fax: (203) 974-8502 Toll Free: 1-(877) 855-2237 WWW.CT.GOV/CAES An Affirmative Action/Equal Opportunity Employer